A Cluster-Randomized Control Trial of a Workplace Resilience Intervention for Child Care Providers' Mental Health & Well-Being

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Work-related stressors take a heavy toll on individuals’ health and well-being as made even more evident by the increased awareness of essential workers during the pandemic and its still lingering impact on workplace settings. Resilience programs have arisen as a promising workplace strategy to improve mental health and well-being for those at greatest risk; however, emerging programs are limited by time- and resource-intensive in-person strategies limiting scalability and practicality for the most marginalized of the workforce. Additionally, the literature on resilience programs are largely from preliminary studies that lack a priori sample size calculations, representative participants, and long-term maintenance following the intervention, as well as inadequate control groups, which limits translation prompting calls for more rigorous designs to evaluate the efficacy of these programs. Consistent with the aim of PAR-24-086 to test a fully remotely delivered clinical trial with no in-person contact, this team has developed and translated the Stress Management and Resilience Training (SMART) program for web-based delivery. Our pilot work demonstrates feasibility, usability, satisfaction, and initial efficacy of the brief self-paced web-based learning sessions (1 hour per week) with only 5-10 minutes of daily practice suggesting a fully powered study is timely and warranted. An adequately powered, cluster randomized controlled trial to test the efficacy of the web-based SMART program compared to a matched attention control in a high-need, representative, under-resourced, and under-studied segment of essential workers – childcare workers - will be conducted. Participants (640 workers from 80 childcare centers) will be randomly assigned to either SMART or a matched attention control condition with the primary outcome of mean change in resilience assets and resources (Connor-Davison Resilience Scale). Measures will be collected at four timepoints: baseline (0 months), post-intervention (3 months), and long-term maintenance (9 and 15 months). Secondary outcomes will include changes in overall mental health, negative and positive mental health indicators, social support, and organizational assets and resources. We will also explore potential moderators’ (e.g., demographics, social determinants of health) influence on treatment effects. The RE-AIM Framework will be used to determine reach and representativeness, and potential for organizational level adoption, implementation, and maintenance of the SMART program. This study fills key gaps of previous resilience research in an underserved population in critical need of mental health and well-being resources with implications for the feasibility and impact of remote programming in other segments of the workforce.

Public health relevance
Resilience interventions are a promising strategy to improve individuals’ mental health and well-being; however, emerging models too often rely on time and resource intensive in-person trainings tested with still largely preliminary research designs limiting confidence in their scalability and impact. This project will use a rigorous clustered randomized controlled efficacy trial to test a fully remotely delivered resilience intervention targeting childcare staff, a high-risk group of essential workers. Results will provide guidance for a scientifically sound, replicable resilience intervention that can be rapidly translated to workplaces.